HEAR-HEARTFELT (Identifying the risk of Hospitalizations or Emergency depARtment visits for patients with HEART Failure in managed long-term care through vErbaL communicaTion)

As a result of efforts to reduce healthcare costs and improve quality, patients with heart failure are increasingly
receiving treatment in community-based programs, such as managed long-term care programs which support
older adults in remaining independent in their community. Managed long-term care aims to reduce unplanned
hospitalizations and emergency department (ED) visits, but heart failure is still the leading reason for these
avoidable events. In managed long-term care, the care coordinator (i.e., a registered nurse or social worker)
maintains regular contact with patients by telephone to ensure that they receive care congruent with their
medical needs. From the linguistic perspective, verbal communications between patients and healthcare
providers are information-seeking and sharing behaviors, as they include problem-focused communication.
From the acoustic perspective, heart failure can affect patients’ voice and speech characteristics due to
swelling caused by fluid retention or compression of the laryngeal nerve due to enlarged heart structures.
While verbal communication between patients with heart failure and their care coordinators can provide insight
into hospitalization and ED risks, it is largely untapped in managed long-term care. To address this gap, we
aim to examine whether audio-recorded verbal telephone communication (hereafter called verbal
communication) can be utilized to improve risk prediction. In the K99 phase, we will focus on identifying
information in verbal communications between patients with heart failure and their care coordinators. We will
extract the following potential risk factors for hospitalizations or ED visits from verbal communications: (1)
conversational characteristics to analyze interactions in patterns of communication, (2) language phenotypes
based on a list of the language of risk factors, including heart failure symptoms, poor self-management, and
other hospitalization risks, and (3) acoustic features by analyzing voice signals. In the R00 phase, we will focus
on developing risk prediction models for hospitalizations or ED visits for patients with heart failure in managed
long-term care. We will develop several machine learning-based risk prediction models for hospitalizations or
ED visits using information derived from: a) structured electronic health records, b) care coordination notes,
and c) verbal communications between patients with heart failure and their care coordinators (identified during
the K99 phase). We will evaluate if the risk prediction performance of machine learning algorithms can be
improved by integrating information from different data sources. This proposal is aligned with the Strategic
Vision key area of the National Heart, Lung, and Blood Institute (NHLBI), "Leverage emerging opportunities in
data science to open new frontiers in heart, lung, blood, and sleep research." This study will be an important
step toward achieving my long-term career goal of developing risk prediction models for heart failure patients
and implementing them into clinical decision support systems. In particular, the goal is to identify early signs of
deterioration by incorporating verbal communication from patients into risk models.

Public health relevance
PROJECT NARRATIVE In managed long-term care, care coordinators (i.e., registered nurses and social workers) periodically communicate with the patients over the telephone to ensure that they receive care congruent with the patient’s health needs. These verbal communications between patients with heart failure and care coordinators may include clues on risk factors for hospitalizations and emergency department visits. With cutting-edge artificial intelligence techniques, this project aims to examine whether audio-recorded verbal telephone communication (i.e., verbal communication) can be analyzed and utilized to improve risk prediction.